Pharmacokinetics and efficacy of intrathecal VersaMab-101 delivery foracute spinal cord injury

PROJECT SUMMARY/ABSTRACT
Every year in the United States, approximately 17,800 people suffer acute spinal cord injuries (SCI).
While recent advances in the medical management of SCI have led to improvements in the diagnosis and
stabilization of these patients, there has been minimal progress made towards improving outcomes with current
treatment options. For instance, fewer than 1% of individuals experience complete neurological recovery by the
time of hospital discharge, and the lifetime costs of living with an SCI can average up to $5.1M for individuals
with high tetraplegia. VersaPeutics is a small business that is developing VersaMab-101, a novel monoclonal
antibody therapy for acute SCI. Traditionally, biologic therapeutics for SCI have been delivered intrathecally via
osmatic pump into the spinal cord. Our previously study has demonstrated the stability of VersaMab-101 in one
of the FDA approved programmable pump under a simulated clinic administration. In the present study, we will
examine the pharmacokinetics and efficacy of intrathecally administration of VersaMab-101 by using rodent
models of SCI. At the end of this project, we expect to have high quality datasets that will inform our clinical
development plans for VersaMab-101 and also will be published to help the spinal cord injury drug development
community.

Public health relevance
NARRATIVE We are developing a novel antibody-based therapy that we hypothesize will provide significant functional benefits to humans with acute spinal cord injuries.